Molecular and metabolic signaling in necrotizing enterocolitis

The goal of the current R35 proposal is to understand the underlying pathogenesis of necrotizing
enterocolitis (NEC), the leading cause of death from gastrointestinal disease in premature infants, and
to develop novel treatments for this devastating disease. The typical patient with NEC is a premature
infant who rapidly progresses from mild feeding intolerance to systemic sepsis and then death within 24 hours.
NEC disproportionately affects communities of color, and half of all patients will require laparotomy, which
reveals patchy intestinal inflammation and necrosis. There is no specific treatment for NEC, which increases
the urgency to develop novel therapies for this devastating disease.
The journey which has led me to write this proposal includes over two decades of research into NEC,
including the advancement of a unifying theorem to explain NEC development, the discovery of several
classes of anti-NEC agents which have been patented, and most recently, the completion as sole Editor-in-
Chief of the first textbook devoted to NEC. This track record gives me a unique vantage point in which to
identify the most important unanswered questions in the field, and the experience to create a plan to answer
them. Prevailing thinking suggests that NEC arises from an exuberant inflammatory response to bacterial
colonization in the premature intestine. In mice and human studies, I discovered that the receptor for gram
negative bacterial lipopolysaccharide, namely toll-like receptor 4 (TLR4), on the intestinal epithelium, is
required for NEC development. TLR4 activity is higher in the premature human and mouse intestinal lining
compared to the full-term intestine, which reflects TLR4's role in governing gut development. The subsequent
activation of TLR4 by colonizing bacteria leads to inflammation and NEC. These observations formed the basis
for my discovery of a novel class of anti-TLR4 molecules that prevent and treat NEC in mice, piglet and human
tissue ex vivo. In the current proposal, we will now address four critical knowledge gaps in the field of NEC
research: 1. What causes NEC and its hallmark patchy intestinal necrosis? To answer this, we will employ
ssRNA-seq in mouse and human NEC tissue and human organoids to discover and then modify TLR4-
dependent genetic pathways causing NEC; 2. How can we prevent NEC? We will assess the role of diet
(breast milk vs. formula) and immunometabolism on the induction of inflammation in the preterm gut and then
manipulate diet-induced inflammatory pathways to reduce NEC; 3. Can we predict NEC earlier? We will
assess cellular and molecular maternal factors that contribute to NEC, image blood flow in the premature gut
non-invasively, and develop machine learning algorithms for prediction; 4. What causes the long term
complications of NEC on the lung, brain and gut? We will perform discovery arrays in humanized organoid
platforms as well as mouse and piglet NEC models to identify the link between the inflamed gut and end organ
injury. These studies promise to significantly advance the field of NEC, and to offer specific therapies for it.

Public health relevance
Project Narrative Necrotizing enterocolitis (NEC) is the leading cause of death from gastrointestinal disease in premature infants, and for which there exists no effective cure. The current proposal has identified four major questions in the field of NEC which we now seek to answer, through a novel focus on identifying what causes NEC, how we can prevent NEC, how we can predict NEC, and how we can reduce the impact of NEC on causing long term complications on the brain, the gut and the lung.